Epigenetic Biomarker Status, Negative Valence, and HPA-Axis Dysregulation: Mechanisms Underlying Risk for Postpartum Depression

PROJECT SUMMARY / ABSTRACT
A key factor in the development of postpartum depression (PPD) is sensitivity to fluctuating reproductive hor-
mones. Consistent with this, prior work has identified two epigenetic biomarkers at estrogen-responsive genes
that predict PPD with consistent replicability with an area under the receiver operator curve >80%. However, the
mechanism(s) by which these epigenetic changes lead to depressive symptoms are unknown, and are likely
distinct from those leading to symptoms in individuals without the epigenetic biomarkers. The Research Domain
Criteria (RDoC) negative valence domain describes responses to aversive and stressful situations, including
fear, anxiety, and sustained threat. Prior literature suggests an “anxious depression” phenotype is prevalent in
PPD, and the applicant has previously shown that negative valence measures have a strong association with
depression severity. Our preliminary data show differing negative valence-related symptoms in those with
and without identified epigenetic biomarkers. Those with the biomarkers display greater anxiety/fear and
have a higher prevalence of new perinatal-onset depression, while those without the biomarkers exhibit chronic
lifetime depression. The hypothalamic-pituitary-adrenal (HPA) axis is a key component of negative valence and
is differentially affected by acute and chronic stress – acute stress upregulates the HPA-axis; chronic stress
leads to HPA-axis hypoactivity. The HPA-axis changes perinatally, and estrogen, which surges during pregnancy
and falls postpartum, stimulates HPA-axis activation. However, there is limited knowledge of HPA-axis function-
ing in PPD, especially in the context of identified estrogen-responsive epigenetic biomarkers of risk. Given dif-
fering presentation of negative valence symptoms (acute vs. chronic stress) in biomarker groups, we propose
that there is a unique HPA-axis vulnerability to PPD, and that this vulnerability differs between those with and
without the biomarkers. We will compare negative valence symptoms and HPA-axis function between biomarker
groups in the context of an ongoing longitudinal study. Our research goal is to confirm stress phenotypes in
biomarker groups and understand what HPA-axis mechanisms contribute to depression severity in each group.
The specific aims are to (1) investigate constructs of fear, anxiety, and chronic stress, and their relationship
with depression severity, in those with and without the epigenetic biomarkers using RDoC self-report measures;
(2) investigate HPA-axis functioning and depression severity in those with and without the biomarkers using
biological/physiologic RDoC measures of stress hormones and heart rate variability; and (3) investigate the HPA-
axis response to a paradigm of induced, acute stress in a subset of individuals with and without the biomarkers.
The training goals are to (1) acquire advanced training in epigenetics; (2) acquire advanced training in HPA-
axis measurement and analysis; (3) develop a thorough understanding of clinical phenotyping in mental health
research; and (4) develop a comprehensive research framework with clinical translation. This training will ad-
vance the applicant towards an independent academic research career in the field of perinatal mental health.

Public health relevance
PROJECT NARRATIVE Pregnant and postpartum women are at an increased risk for developing mood disorders. This study investigates differences in stress experiences and stress responses in pregnant and postpartum women with and without an identified biological marker of risk for postpartum depression. Findings will help to identify mechanisms and risk factors contributing to postpartum depression and inform novel treatments.